FAK mediates noise-induced loss of auditory hair cell function and survival

Project Summary
Mitochondrial dysfunction has long been recognized as an underlying mechanism of noise-induced loss of
hearing sensitivity (NIHL). However, the initiating processes that lead to this dysfunction is poorly understood.
This proposal is founded upon new and important findings involving changes in mitochondrial dynamics in outer
hair cells after loud sound exposure. Mitochondria are highly dynamic organelles that constantly undergo fission
and fusion to adapt to changes in the cellular environment, and it is becoming increasingly clear that
mitochondrial morphology is directly related to mitochondrial function and, therefore, the health and survival of
the cell. The studies proposed here will examine a potential integrin signaling pathway for induction of
mitochondrial fission activity. Specifically, we will investigate the role of FAK as a mediator of noise-induced
overstimulation of OHCs leading to cell death and loss of hearing sensitivity.

Public health relevance
Project Narrative Mitochondria perform a critical role in maintaining cell health and survival, and loss of proper mitochondrial function has long been recognized as cause of noise-induced hearing loss (NIHL). The sensory cells of the auditory system are easily damaged and killed by loud sound resulting in loss of hearing sensitivity. Completion of the studies proposed here will result in a better understanding of the mechanisms leading to mitochondrial dysfunction revealing new targets for the prevention and treatment of NIHL.